Combined Cardiomyopathy, e.g., of Cancer Chemotherapeutics, and Proarrhythmia for Cardiotoxicity Clinical Trials-in-a-Dish (CTiD) with iPSC-Derived Cardiomyocytes

Cardiotoxicity is a leading cause of drug discovery attrition across all of preclinical and clinical drug discovery.
While the FDA and the Comprehensive in vitro Proarrhythmia Assay initiative (CiPA) are focused primarily on
predicting proarrhythmic effects, drug attrition due to cardiomyopathy, or primary cardiac cytotoxicity, may be
even more prevalent, is typically currently only carried out via animal studies, and limits dosage for many
cancer chemotherapeutics. Due to improving cancer survival, it is increasing common for more cancer
survivors of some cancer types to die of cardiac diseases due to cancer treatment side effects than cancer
recurrence. Cardiac contractions are initiated by electrical depolarizations (action potentials, APs) that
propagate through the heart and initiate calcium (Ca2+) transients that activate the contractile apparatus.
Importantly, dysregulation of Ca2+ can trigger inappropriate early-after- and delayed-after- depolarizations
(EADs and DADs) that initiate arrhythmias, inhibit mitochondrial function, and pathologically alter expression of
contractile proteins. Chemotherapy and other drugs can also directly impair mitochondrial function, which is
primarily thought to cause cytotoxicity, but can also cause arrhythmias. Cardiomyocytes are also
heterogeneous in their voltage, calcium, and contractile functions, and in their responses to therapeutic
candidates. Thus, it is highly desirable to simultaneously measure AP, Ca2+ and contractile function on a cell-
by-cell basis, in human cardiomyocytes, but this is not possible with current test methods. To address this
unmet need we propose to develop a high throughput (robotic) Kinetic Image Cytometry that simultaneously
quantifes voltage, calcium, and contractile motion in cardiomyocytes derived from human induced pluripotent
stem cells (hiPSC-CMs). The hiPSC-CMs will be labeled with fluorescent indicators of calcium and voltage,
and the cells imaged via high-speed automated microscopy during contractile activity. The use of hiPSC-CMs
will enable “clinical trials” in a dish, in which test compounds are tested across cells representing several
donors. Phase I of this Fast-Track STTR project will develop the basic protocol and perform a proof-of-concept
screen of 30 test compounds on hiPSC-CMs representing 5 donors. In Phase II, a large validation study (~350
compounds, 7-concentration dose-response, 30 min and 72 hr exposures) will be performed. Artificial
intelligence will be utilized to optimize the sensitivity and specificity of the assay by detecting complex
arrhythmia waveforms. This assay represents a human-based preclinical model that will be less expensive
and more predictive for cardiotoxicity testing than animal models and will be marketed to the pharmaceutical
industry for contract research.

Public health relevance
FDA guidelines stipulate that all new drugs be tested for dangerous side-effects on the heart as part of preclinical research; however, the current tests are poorly predictive of both dangerous and safe drugs leading to unwarranted attrition and dangerous drugs reaching clinic. Human cardiomyocytes derived from donor tissue (iPSC-derived cardiomyocytes) are widely considered to hold great promise for clinical trial in a dish studies of drug cardiotoxicity. This STTR proposal is to commercialize a high throughput platform to accurately identify drug candidates that have cardiac side effects, in particular adding the ability to detect the type of primary heart cell damage common with anti-cancer drugs in a fully automated (high throughput) robotic assay for the first time, to improve the efficiency of preclinical research and the safety of human clinical trials, which will also likely have the added benefit of reducing animal research.